Role of hypothalamic IRF3 transcriptional dysregulation in obesity

Abstract
Arriving at a more granular understanding of the molecular drivers of appetite will represent a major step
towards the ultimate goal of more efficiently treating obesity. AgRP neurons in the arcuate nucleus (ARC) of
the hypothalamus play a dominant role in maintaining energy balance and are dysregulated in obesity. We
have recently utilized cutting-edge tools to enable an unprecedented cell type-specific characterization of the
transcriptional and epigenomic landscape of AgRP neurons, and this information was leveraged to identify one
transcription factor, Interferon Regulatory Factor 3 (IRF3) that mediates the acute anorectic effects of leptin.
The current project seeks to examine the role of AgRP neuron IRF3 (IRF3AgRP) in the development of diet-
induced obesity (DIO) involving loss- and gain-of-function experiments while assessing the impact on mouse
body weight, feeding behavior, and leptin sensitivity. The transcriptomic profiles of these IRF3 functional
mouse models will be examined in the lean state in response to leptin, and in the obese state. Additionally, the
direct DNA binding targets of IRF3AgRP will be elucidated using a cutting-edge, low-input, alternative to ChIP-
seq called CUT&RUN, all in the lean fed, fasted, and leptin treated state, and in response to obesity. AgRP
neuron-specific ATAC-seq for lean and obese AgRP neuronal nuclei will also be performed as a means of
assessing the transcriptional regulatory status of IRF3 and other TFs during obesity. Finally, using both lean
and obese mice that are either wild-type or have IRF3 knockout out of all leptin-receptor expressing cells, I will
perform single nucleus RNA-seq as a means of identifying the IRF3-driven transcriptional programs onboard in
the obese state. Overall, these studies will test the overarching hypothesis that IRF3 plays key roles in
mediating both acute leptin sensitivity as well as the development of diet-induced obesity owed to chronic IRF3
activation via hyperleptinemia. The regulatory pathways highlighted in this project will point to novel therapeutic
targets for the treatment of obesity, a major risk factor for type 2 diabetes. During the course of the mentored
phase of this application, I will further strengthen the computational skills needed to analyze RNA-seq, ATAC-
seq, CUT&RUN, and single-nucleus RNA-seq datasets independently. I will also engage in various career
development experiences, while also receiving invaluable mentorship from my career advisory committee. In
all, the funding of the proposed project will ensure that I round out my scientific and professional training while
laying the foundation for a viable independent academic research program.

Public health relevance
Project Narrative Leptin-sensitive neurons within the hypothalamus, including AgRP neurons, play a dominant role in regulating appetite, and until recently we did not have the tools needed to study the transcriptional regulatory processes that govern their activity during the development of obesity. This project will utilize cutting-edge cell-type specific genomic profiling techniques to study a newly identified transcription factor, Interferon Regulatory Factor 3 (IRF3) in leptin-sensitive neurons, including, AgRP neurons (IRF3AgRP) that is both regulated for acute leptin sensitivity and is potentially disrupted during states of hyperleptinemic diet-induced obesity. The transcriptional pathway investigated in this project will aid the discovery of novel therapeutic targets for the treatment of obesity.